Identifying novel microproteins and protein translation mechanisms involved in the development of atherosclerosis

PROJECT SUMMARY/ABSTRACT
Bile acids have been implicated as a contributor to atherosclerosis and is commonly found to be elevated in
patients with metabolic disorders and cardiovascular disease (CVD). Recently, we observed extrahepatic bile
acid release in high-fat/high-sucrose (HFHS) fed and LDLR KO pig models of atherosclerosis. To reveal novel
targets to treat BA abnormality in patients with CVD, we aim to use the deep-sequencing technique, ribosome
profiling (ribo-seq), to investigate translational control of BA synthesizing and trafficking genes in colon, kidney,
liver, and muscle in HFHS-fed and LDLR KO atherogenic pig models (Aim 1). Additionally, Ribo-seq can be used
to identify small open reading frames (smORFs) which encode microprotiens. These microprotiens are often
overlooked and underappreciated as key players in biology and are highly enriched in mitochondria and often
found to perturb metabolic processes. Thus, we aim to filter Ribo-seq data for smORFs encoding mitochondrial
microproteins and determine their impacts on cellular metabolism using untargeted metabolomics/lipidomics
followed by relevant stable isotope tracing to identify affected enzymes/pathways.

Public health relevance
PROJECT NARRATIVE Atherosclerosis, which is driven by plaque buildup in the arteries, is a major cause of heart disease and has been associated with elevated bile acid levels. We have previously discovered extrahepatic bile acid release (under revision in Cell) and to address this result, we propose implementing ribosome profiling (Ribo-seq) and RNA sequencing techniques to identify translationally regulated genes contributing to bile acid (BA) abnormality in liver, muscle, kidney, and colon; all of which are tissues which we found to show high induction of BA synthesis (Aim 1). Additionally, we will use this Ribo-seq data to identify novel microproteins relevant to the development of atherosclerosis.